Global HIV Implementation Science Research Training Grant Renewal

PROJECT SUMMARY/ABSTRACT
While the scale of the HIV epidemic remains large, it has entered a promising new phase, marked by
unprecedented progress and opportunities. In view of the need to rigorously test interventions to improve the
uptake, implementation, and translation of recent scientific findings into standard of care (the know-do gap), as
well as to evaluate the impact of bringing such interventions to scale, in 2014 we launched a research training
program focused on Global HIV Implementation Science. Implementation science is the scientific study of
methods to promote integration of research findings and evidence-based interventions into health care policy
and practice, thus improving the quality and effectiveness of health services. A key element of translational
research, implementation science encompasses a broad range of skills, including epidemiology, biostatistics,
sociology, decision science, and health economics.
The long-term objective of the Training Program is to prepare well-qualified individuals for careers as
independently-funded researchers and for leadership in global HIV implementation research. We have
assembled an outstanding group of diverse faculty from multiple schools, departments, and centers at
Columbia University who have distinguished themselves in mentorship and are leading cutting edge
implementation science research addressing HIV prevention among key populations, adolescents and young
women; engaging adolescents and men in the care continuum; TB/HIV integration; and differentiated service
delivery. The Training Program encompasses streamlined coursework based on an individualized training plan;
weekly faculty-fellow seminars; tailored mentorship; research experience in a variety of domestic and
international field settings; presentations; manuscript and grant preparation; research seminars and colloquia;
and instruction in the responsible conduct of research. The Training Program also includes rigorous evaluation
of the quality and effectiveness of the Training Program, to ensure that trainees achieve the competencies and
skills necessary for success as future leaders in HIV implementation science research.
The five-year program aims to support seven (five predoctoral and two postdoctoral) trainees at any one time.
Among the postdoctoral trainees, a mix of trainees with PhD, DrPH, and MD degrees is sought. Predoctoral
trainees are required to pursue a doctoral degree in Epidemiology. The period of support is three years for
predoctoral candidates and two years for postdoctoral candidates. With stellar faculty, a unique training
environment, and unparalleled research opportunities in domestic and international field settings, we are well-
poised to continue to lead this novel effort and nurture new investigators trained in multidimensional,
interdisciplinary approaches to advance scientific knowledge and demonstrate the impact of interventions.

Public health relevance
PROJECT NARRATIVE Despite recent advances in prevention and treatment, the scale of the HIV epidemic remains large. The Global HIV Implementation Science Research Training Program aims to increase the number of independent investigators with the knowledge and skills needed to rigorously test interventions to improve the uptake, implementation, and translation of recent scientific findings into standard of care (the know-do gap), as well as to evaluate the impact of bringing such interventions to scale. With stellar faculty, a unique training environment, and unparalleled research opportunities in domestic and international field settings, we are well-poised to continue this novel effort and nurture new investigators trained in multidimensional, interdisciplinary approaches to advance scientific knowledge and evaluate the impact of interventions which address this public health challenge.